SCHERING SCH 39166 AS TREATMENT FOR COCAINE ABUSE IN HUMANS

D1 receptors may play an important role in mediating cocaine's addictive properties. We are proposing to use our laboratory model of repeated dose cocaine self-administration to assess the potential efficacy of the D1 receptor antagonist, SCH39166, for the treatment of cocaine dependence. Non-treatment seeking cocaine abusers will live on the hospital unit and will be maintained on placebo and SCH39166 each for 8 days to determine if the medication alters cocaine's reinforcing effects.